Preventing Exposure to Ticks and Tick-Borne Illness in Outdoor Workers

Preventing exposure to ticks and tick-borne illness in outdoor workers ABSTRACT In North Carolina, tick-borne diseases represent a growing public health problem and an occupational hazard for outdoor workers. Currently, tick-bite prevention requires time- consuming reapplication of insecticides to clothing and exposed skin. Unfortunately, adherence to these procedures is poor. Recently, a factory-based method for long- lasting permethrin impregnation of clothing has been developed which allows clothing to retain insecticidal activity for over 70 washes (the effective lifetime of a garment). The treatment process has been approved by the US EPA and classified as non-toxic. We have preliminary evidence from a small pilot project suggesting that workers wearing this clothing have ~90% fewer tick bites than workers not wearing this clothing. In order to measure the effectiveness and safety of this clothing in protecting outdoor workers, we are proposing a randomized controlled intervention with 300 workers in the NC State Department of Environmental and Natural Resources (DENR). Outdoor workers in the Division of Forestry and the Division of Parks and Recreation will be randomly assigned to two groups. Workers will have their uniforms treated or sham-treated in a double- blinded manner. All study subjects will fill out weekly tick logs, and keep removed ticks in specimen vials for later speciation and pathogen detection. Serum samples, drawn at enrollment and study conclusion will be titered for antibody to common tick-borne pathogens. Possible clothing-related adverse events, such as rashes, will be recorded. The results of this study could lead to a simple and cost-effective method of protecting outdoor workers from tick-borne illnesses.

Public health relevance
Project narrative Tick-borne infectious diseases are a major occupational hazard for outdoor workers, including employees of the North Carolina State Department of Environment and Natural Resources. This project involves testing the effectiveness of long-lasting permethrin- treated uniforms in reducing tick exposures in North Carolina Forestry and Parks Department employees. __SpecificAimsTextDelimiter__ SPECIFIC AIMS The high risk of acquiring tick-borne diseases by outdoor workers is well documented [1-36]. Workers most at risk include, foresters, park rangers, land surveyors and other outdoor workers have frequent exposure to tick-infested habitats. Many North Carolina state employees with outdoor occupations report multiple tick bites each year, which indicates that existing tick preventive strategies may be ineffective. The principal goal of this study is to assess whether the use of long-lasting permethrin impregnated uniforms can reduce the number of tick bites sustained by North Carolina outdoor workers. The study will enroll outdoor workers from Central and Eastern North Carolina who are employed by the North Carolina Department of Environment and Natural Resources in the Division of Forest Resources and Division of Parks and Recreation. Participants who are enrolled in the study will be randomized in a double-blind manner into two groups to wear either treated or untreated uniforms. Subjects will be followed for two calendar years. In this study the principal specific aim is to: " Evaluate the effectiveness and safety of long-lasting permethrin-impregnated uniforms in preventing tick bites in outdoor workers. Secondary specific aims are to: " Measure exposures to tick-borne pathogens among study subjects by serology " Determine the prevalence of infection with bacterial pathogens among collected ticks using PCR